Summer Research Training in Aging for Medical Students

The proposed T35 program will provide annual financial support for up to sixteen medical students to
spend eight weeks during the summer between first and second years of medical school working on aging-
related research. For this renewal application, the T35 program’s objectives remain: (1) to provide students
excellent research mentors and aging related research projects to stimulate their interest in aging
research; (2) to engage medical students and spark their interests in principles of clinical care for older
adults and in geriatric medicine; (3) to run a high quality program that identifies highly qualified
students, assures strong mentorship, and optimizes the probability that research will lead to
presentations and publications and future careers in aging research and geriatric medicine; and (4) to
acquire data to judge the success of the program and to modify the program to make it more
successful. The Summer Research Training in Aging for Medical Students program will coordinate with
the American Federation for Aging Research (AFAR) so that students from other medical schools, as well as
NYU Grossman School of Medicine (GSoM) students, can participate.
An experienced Geriatrician and researcher will be the Program Director (PD) assisted by two
Associate Program Directors (APDs) familiar with career mentoring for medical students, geriatric curriculum
development, and the NYUGSoM’s new curriculum that emphasizes research. An internal advisory board
(IAB) will advise the PD and APDs on selection of mentors and projects, review evaluation metrics, and
suggest program improvements.
Each year the PD and the IAB will select experienced researchers who are also successful mentors,
and solicit from them aging research projects for students. These researchers will work closely with students
during their summer experience to ensure the successful implementation of a research project suitable for
abstract, presentation and publication.
Throughout the eight weeks, students will participate in weekly interactive didactic session related both
to research and to geriatrics/aging. Students will also have the opportunity for clinical experiences
appropriate for rising second year students. At the end of their experience, students will formally present
their research projects to other students and mentors. They will also be required to submit an abstract for
the American Geriatrics Society (AGS) Annual meeting, and/or another professional society. Students will
be strongly encouraged to attend these meetings to present their research. To track the success of the
program, students and mentors will be surveyed at the end of the program regarding their experience, and
how the program can be improved. Students will also be surveyed in the middle and end of medical school
and at the end of residency, to assess their career achievements and goals related to aging and research.

Public health relevance
Narrative The Summer Research Training in Aging for Medical Students Program, will accept up to sixteen medical students between their first and second year of medical school. The program will coordinate with the American Federation for Aging Research to allow both NYU School of Medicine and students from other medical schools to participate. Students will have eight weeks of research training with experienced research mentors and faculty mentors who will introduce them to clinical geriatrics, didactic sessions on research methods, aging processes and geriatrics, and will be expected to present their research locally as well as at the American Geriatrics Society (AGS) Annual Meeting.